Video-based Collaborative Learning to Improve Ventral Hernia Repair

PROJECT SUMMARY/ABSTRACT
To preserve healthcare resources and capacity for an anticipated but uncertain wave of patients with SARS-
CoV2, hospitals across the United States stopped performing non-essential surgery in March 2020. The ability
to generate capacity by reducing non-essential surgery comes at significant cost to patients, clinicians, and
health systems, particularly small rural hospitals that rely on these services to remain solvent. There is an
urgent need to maximize opportunities to perform non-essential surgeries to the extent that is safe under a
broad range of systemic demands, for the duration of this pandemic and beyond.
Numerous organizations, including the American College of Surgeons (ACS), the American Hospital
Association (AHA), and the Centers for Medicare and Medicaid (CMS), have provided broad guidelines for
tiering and prioritizing operations to guide this process of modulating non-essential surgical care. While these
provide an excellent high-level framework for stopping and resuming non-essential surgery, they have two
limitations in that they: 1) rely on individual hospitals to develop an approach appropriate for their individual
institutional context without providing tools for doing so; and 2) do not provide guidance on the predicted need
for an approach to modulate non-essential surgery as the pandemic fluctuates in upcoming months. In
addition, there is an urgent need for data regarding the magnitude of backlogged surgical demand. We
propose to fill these gaps by building on existing work with the Surgical Collaborative of Wisconsin (SCW) and
the Americas Hernia Society Quality Collaborative (AHSQC) and our extensive experience using discharge
data to evaluate the use of best practice in surgery. We will quantify and characterize the impact of COVID-19
on general surgery care in the state of Wisconsin and develop implementation resources that can be used to
support individual practices as they contextualize and adapt general best practices. We will then evaluate the
knowledge utilization and generalizability of the resulting multi-faceted implementation intervention through our
existing partnerships with a regional (SCW) and national (AHSQC) collaborative. Given the broad approach
that we propose, results will be scalable across the United States and applicable in future disaster situations.

Public health relevance
PROJECT NARRATIVE This proposal aims to develop a multi-faceted intervention to help surgeons and institutions modulate non- essential surgical care under a broad range of systemic demands, for the duration of the COVID-19 pandemic and beyond. At the same time, we will add significantly to our knowledge of the impact of COVID-19 on non- essential surgical care and how health systems have responded to the pandemic. Given the broad, generalizable approach that we propose, results will be scalable across the United States and applicable in future disaster situations.